A dual-purpose hu-mouse model for evaluating SIV and HIV cure strategies

Project Summary/Abstract:
Due to their proven track record in HIV research, NHPs will continue to play a major role into the foreseeable
future in HIV cure research. However, the wider use of NHPs is somewhat restrictive due to their high cost
and limited supply. In this regard, a small animal model that can serve as a preliminary in vivo screen for the
initial evaluation of promising, in vitro-tested, new drugs prior to their evaluation in SIV infected NHPs would
be of great benefit in saving time, and in helping to formulate more informed studies. If this same animal
model could also allow for the testing of drugs against HIV directly, it would serve two major purposes i. e.,
the simultaneous ability to test drugs active against both HIV and SIV. In our ongoing work on SIV progenitor
viral evolution into HIV, we discovered that humanized mice (hu-mice) transplanted with a human immune
system are susceptible to SIVs, namely SIV-chimpanzee (SIVcpz) and SIV-sooty mangabey (SIVsm) that
gave rise to HIV-1 and HIV-2, respectively. This forms a basis for our proposed work here to develop and
investigate a versatile small animal model that can facilitate the testing of anti-HIV and/or anti-SIV drugs as
well as broadly neutralizing antibodies (bNAbs). If successful, this will be a unique model that would benefit
both the HIV and SIV research groups involved in cure strategies to streamline their testing pipelines more
effectively using the same drugs or biologics on two different viruses within the same animal model. Our
specific aims are:
Aim 1: Evaluate the humanized mouse model for productive and chronic infection with frequently used SIVs
and SHIVs in AIDS research such as SIVmac251, SHIVSF162P3 and RT-SHIV.
Aim 2: Validate the utility of the hu-mouse model for in vivo efficacy testing of new generation ARV drugs
against SIV and SHIV viruses, namely, NRTI Tenofovir alafenamide (TAF), Islatravir, (4'-ethynyl-2-fluoro-2’-
deoxyadenosine, EFdA), Cabotegravir (CAB), and Lenacapvir (GS-6207)
Aim 3: Investigate the hu-mouse model for in vivo efficacy testing of bNAbs against SIV and SHIV viruses:
Here will evaluate select HIV bNAbs 10-1074 and 3BNC117 on SHIV viruses and bNAbs against SIV
ITS103.01 and ITS90.03 in the hu-mouse system
Aim 4: Evaluate viral latency reversal and potential cure strategies on SIV/SHIV viruses in the hu-mouse
model system: A select combinatorial approaches that incorporate ARVs, LRAs, TLR agonists, and bNAbs
against SIV and SHIV to validate the utility of hu-mice in HIV/SIV cure research.

Public health relevance
Project Narrative: For HIV/SIV cure research we propose to develop a humanized mouse model susceptible to both HIV and SIV as a hybrid dual-purpose model to enable testing of therapeutics against both viruses. Cure strategies involving a combination of LRAs, ARVs and bNAbs will be evaluated to validate this model using SIVs. If successful, these studies are likely to break new ground and provide a versatile small animal model for HIV and SIV studies.